Administrative Core

Administrative Core
SUMMARY
The Administrative Core’s overall goal is to provide administrative support to ensure the successful
accomplishment of our ICEMR Center’s scientific and public outreach goals. This ICEMR seeks to
assess over time the impact of a new invasive malaria vector, Anopheles stephensi, and urbanization
on malaria epidemiology and transmission in rural to urban landscapes in Ethiopia. This Center
involves numerous investigators based at institutions in the U.S. and Ethiopia. This Center’s success
depends on a well-developed administrative plan that effectively coordinates multiple collaborating
institutions and government agencies. Thus, this Administrative Core will coordinate and supervise
the entire range of Center activities, monitor progress, and ensure that each project’s milestones are
being met and implemented effectively within the proposed timelines. This Core has four major goals:
1) to coordinate and supervise the Center’s research activities to ensure the accomplishment of its
scientific goals; 2) to provide financial management for the Center to ensure that the U.S. federal
government and NIH fiscal rules are followed, including the effective management of subcontracts at
participating domestic and international institutions; 3) to foster outreach activities to promote
collaborations with the Ministry of Health of Ethiopia and other ICEMR centers in other malaria-
endemic regions; and 4) to organize and coordinate training of students, junior scientists and project
scientists in data management, biostatistics, malaria epidemiology, and vector biology techniques.
Our previous ICEMR’s well-developed administrative structure and outstanding experience promise
that the proposed ICEMR’s management plan will effectively facilitate the Center’s goal of
multidisciplinary research, capacity building, and scientific collaboration.